Toward Sustainable Growth in the Pac Basin: Coping with

[unreadable] DESCRIPTION (provided by applicant) [unreadable] [unreadable] This is an international research and policy meeting to discuss scientifically based hazardous waste [unreadable] management practices that protect human and environmental health in the Pacific Basin. The conference brings together regional experts in waste disposal and human and environmental health to exchange scientific information pertinent to the management of hazardous wastes. Demographic and economic trajectories among Pacific Rim nations highlight the need for innovative approaches to waste management for health protection. The Asian-Pacific region enjoys the most rapidly growing economy in the world. To sustain current rates of economic expansion and protect human health and environmental values, it is necessary to address hazardous waste disposal problems of an unprecedented scale. The conference is the eleventh in a series of international meetings organized by the Pacific Basin Consortium, many of which were co-sponsored by the East-West Center, the NIEHS SBRP, and various other organizations. Previous conferences spawned international, interdisciplinary relationships among institutional representatives and other conference attendees. The conference will address contemporary environmental problems in the Pacific region, building on an existing knowledge base and strengthening existing institutional and professional interactions. This three-day conference includes sessions on hazardous contaminants and human/environmental health, air pollution in the Pacific Basin region and Pacific Basin vulnerability to global climate change and periodic catastrophic events. The conference organizers are requesting funds from the NIEHS for the portion of the meeting that addresses hazardous contaminants and human/environmental health. [unreadable] [unreadable] [unreadable]